Can the natural environment enhance developmental plasticity and adult adaptive behavior? Effects of naturalistic rearing environment on gene expression, adult brain organization, and behavior.

Project Summary
The neocortex is a uniquely mammalian feature, one which facilitates profound behavioral flexibility. Part of this
flexibility comes from the capacity of the neocortex to be shaped by early sensory and motor experience,
allowing the organism to tune its sensory system to the specific problems and opportunities of the environment
in which it is reared. This developmental plasticity allows an animal to then generate adaptive behavior that
best meets the variable demands of its environment throughout its life. It has been well established that early
sensory experience can alter the sensory or motor representation within a cortical field (cortical maps), neural
response properties, and cortical and subcortical connectivity. However, most studies manipulate one
particular stimulus in what are necessarily very controlled and restricted environments. Further, it is not known
if the differences in the dynamic nature of a given environment (restricted or highly variable) are responsible for
brain/behavior alterations early in development, or if a highly dynamic environment can increase the capacity
for further change in adult behavior. In the current proposal, we take advantage of a unique resource at UC
Davis – field pens located on our Riparian Reserve that are 3,000 times the size of a standard laboratory cage.
These field pens provide a highly enriched and dynamic semi-natural environment in which to rear rats. We will
quantify tactile natural scene statistics between the semi-natural and laboratory environments, allowing us to
quantify differences between the two rearing stimulus conditions, and to subsequently test each group of
animals with the full set of stimuli that both groups experienced during development. A number of features of
brain organization, gene expression, and behavior will be compared between laboratory rats and rats reared in
these semi-natural, highly enriched conditions. While this semi-natural rearing may affect numerous genes,
behaviors, and brain regions, we focus on genes associated with cortical development, areal boundary
formation, and plasticity. We will sample developing animals to quantify changes in gene expression during
critical periods, and relate this expression to adult performance from the same cohort (litttermates) on
behaviors that require sensorimotor integration and coordination in adults. We will further quantify neural
phenotypes of primary somatosensory cortex (S1), investigating somatotopy, receptive field shape, and
cortico-cortical and cortico-thalamic connections. We believe this modality will be highly impacted because the
large space available in the field pens will promote active tactile exploration for navigation and social
interaction. This is the first study that investigates how early exposure to the rich array of natural stimuli and
vastly increased movement options occurring in a natural environment impacts gene expression, neural
phenotypes, and behavior.

Public health relevance
Project Narrative The proposed experiments will examine how early life experience impacts developing cortical organization and connectivity to support adaptive sensory mediated behavior and learning outcomes in adulthood. We will quantify stimuli present in naturalistic vs conventional rearing conditions, and link these environmental features to patterns of neuroplasticity-related gene expression and adult performance on sensorimotor-mediated tasks in siblings of the same cohort, and then assess adult somatosensory cortical function and connectivity in the same adults. These data have implications for how experience guides the course of human brain development and how adaptive and aberrant behaviors emerge and are perpetuated in a population.